Impact of sleep-wake circuits on cortical synapse plasticity during motor learning

Abstract
We still wonder why we sleep. We know at least that sleep helps our memory. Almost every stages and
features of sleep are involved memory consolidation, including non-rapid eye movement slow wave sleep
(NREM SWS), NREM spindles, REM theta rhythm and sleep architecture continuity. Disruption of these
stages and features are found in all neurological disorders afflicting memory (Angelman, autism spectrum,
alcoholism, Alzheimer's, fragile X, Huntington's, Parkinson's, Rett etc…). The mechanisms underpinning
these memory deficits are poorly understood and the role of sleep at the synapse is still highly debated.
Synpases are the central physiological structures underpinning memory and cognition, but how each sleep
stages and features remodels synapses remains unclear. NREM SWS and total sleep have been implicated
in general synaptic downscaling, but NREM and spindles have also been involved in synaptic strengthening;
similarly REM has been associated to both synapse pruning and maintenance. One major obstacle to such
study has been that sleep stages and features are all interconnected and integrated. The disruption of one
often impacts the others making the association between a stage/feature and a specific synaptic function
challenging. Using precise optogenetic control of neuronal circuits, we have overcome this obstacle. Sleep
continuity and memory consolidation can be disrupted without changing overall sleep architecture and
quantity by introducing micro-arousals (<2sec) every 60 sec using hypocretin neuron stimulation (Aim 1).
NREM sleep spindles and memory consolidation can be elicited by stimulating reticular thalamus neurons
without disturbing sleep (Aim 2). Theta rhythms and memory consolidation can be disrupted by silencing
medial septum GABA neurons during REM bouts only without affecting sleep architecture integrity (Aim 3).
We will manipulate these three sleep features after a cortical motor learning task which rapidly induces
synapse formation in the motor cortex. Remodeling of these newly formed synapses and their neighbors will
be followed using state-of-the-art in vivo (two-photon) and ex vivo (array tomography) synapse microscopy.
While the former longitudinal analysis will uncover the spine dynamics leading to memory encoding
consolidation, the latter global synapse analysis will reveal how synapse classes (inhibitory, excitatory),
synapse populations (depending on layers) and their subsynaptic molecular components are remodeled by
sleep continuity (Aim 1), spindles (Aim 2) and REM specifically (Aim 3). The specific use of optogenetics to
manipulate different sleep stages as synaptic dynamics are studied is unprecedented and will shed important
light on how sleep continuity, NREM spindles, and REM can each influence cortical synaptic plasticity
underpinning memory consolidation after motor learning. These discoveries are crucial for future strategies to
recover and treat memory and cognitive deficits in neurodevelopmental and neurodegenerative disorders.

Public health relevance
Narrative Sleep is crucial for memory consolidation and most if not all of its features and stages are implicated in these processes. However it is still unclear how each sleep feature contributes to the remodeling of synaptic connections necessary to stabilize memories. One major obstacle has been that sleep stages and features are all interconnected and integrated. Thus the disruption of one often impacts the others making the attribution of a specific role to REM independently of NREM for example very difficult. Using precise optogenetic control of neuronal circuits in charge of different sleep features or stages, we can now modify one feature at a time after a learning task. Combined with state of the art in vivo and ex vivo synapse microscopy we can reveal how specifically NREM sleep continuity, NREM sleep spindles and REM theta band activities each remodels synapses structurally and molecularly to enable memory consolidation. As most neurodevelopmental and neurodegenerative disorders display sleep abnormalities and associated memory impairment, a positive outcome of this project leads to better strategies to recover and boost memory and cognition performance.